Evaluation of a Candidate Therapeutic for Dengue Virus

EVALUATION OF THE ANTIVIRAL ACTIVITY OF A CANDIDATE DENGUE THERAPUETIC AGAINST DENGUE INFECTION IN A HUMAN CHALLENGE MODEL IN FLAVIVIRUS-NAÏVE HEALTHY ADULT SUBJECTS.